Integrating Maternal and Child Health Services: Development and Pilot Testing of a Pediatric Clinic-Based Postpartum Contraception Intervention

PROJECT SUMMARY/ABSTRACT
While most postpartum women desire pregnancy prevention, fewer than half resume contraception in the
postpartum period. Finding approaches to supporting women’s reproductive goals during this critical transition
can promote reproductive health equity and prevent the adverse maternal and perinatal outcomes that are
associated with undesired, short interval pregnancies. Postpartum women commonly do not attend a
postpartum obstetric visit and face other unique barriers to getting their contraceptive needs met. A novel
opportunity to augment the existing system for delivering postpartum contraceptive care is the pediatric clinic,
where providers frequently and reliably interface with new mothers at infant visits. The proposed Aims will lead
to the development and testing of a pediatric clinic-based approach to enhancing access to postpartum
contraceptive care. A long-term goal of this research is to optimize how pediatricians incorporate evidence-
based, child-relevant aspects of maternal health and social needs into practice. For this four-year K23
proposal, the objective is to develop and pilot test a scalable pediatric clinic-based intervention designed to
meet the contraceptive needs of postpartum women and promote equitable access to contraceptive care. The
central hypothesis is that the pediatric clinic is a feasible and acceptable setting to identify and address unmet
postpartum contraceptive needs. The rationale for this study is that a postpartum contraception intervention,
developed using implementation science principles and stakeholder-engagement methods, has the potential to
prevent undesired pregnancies, support healthy birth spacing, and promote health equity for women and
families. The central hypothesis will be tested by pursuing three Specific Aims: (1) Qualitatively assess
intervention preferences for pediatric clinic-based postpartum contraceptive services among women and
healthcare team members (n=50), (2) Develop a pediatric clinic-based postpartum contraception intervention
through iterative focus groups and usability testing with patient and clinical stakeholders, and (3) Implement
and pilot test the pediatric clinic-based postpartum contraception intervention, measuring feasibility and
acceptability outcomes (n=50). The proposed Aims focus on postpartum contraceptive needs, but the
approach will serve as a model for future efforts to integrate perinatal maternal and child health services to
meet the health and social needs of women and children.

Public health relevance
PROJECT NARRATIVE The goals of the proposed research are to develop and pilot test a patient-centered, pediatric clinic-based postpartum contraception intervention that will promote equitable access to care. The relevance of this research to public health lies in its potential to transform perinatal maternal and child health services to better meet women’s postpartum contraceptive needs, and to therefore improve related health and social outcomes for women and families. This research aligns with NICHD research objectives, including setting a foundation for healthy pregnancies, improving child health, and the cross-cutting topic of health disparities.